Genetic Elements Controlling Blood Pressure

DESCRIPTION (provided by applicant): Among all the hypertensive subjects combined, >90% develop hypertension for no known reasons, also called as Essential hypertension. Although it is well known that genetics play a major role in conferring susceptibility to develop essential hypertension, the identities of the genes/genetic factors that are causally responsible for essential hypertension remaining largely unknown is the single biggest rate-limiting factor in advancing our understanding of the etiology of essential hypertension. Using a rat genetic model for hypertension, we have located regions on the rat genome as responsible for controlling BP. This region, if mapped to the resolution of single genetic elements, can then be utilized for querying similar genetic elements as causative of hypertension in humans. The aims of our proposal are to therefore identify the genetic determinants of BP on three regions that we have already fine-mapped. The significance of our proposal is that it is potentially on the verge of unraveling novel genetic factors in the etiology of Essential Hypertension. PUBLIC HEALTH REVELANCE: Genetics is well recognized to be an important factor that contributes to the development of hypertension, which leads to cardiovascular related illnesses. The research work described in this proposal pertains to improve our current, significantly limited understanding of the identities of genes that control blood pressure. Knowledge gained through successful completion of the work described is expected to identify genetic factors that have not been previously suspected to cause hypertension.

Public health relevance
Genetics is well recognized to be an important factor that contributes to the development of hypertension, which leads to cardiovascular related illnesses. The research work described in this proposal pertains to improve our current, significantly limited understanding of the identities of genes that control blood pressure. Knowledge gained through successful completion of the work described is expected to identify genetic factors that have not been previously suspected to cause hypertension.